Leveraging machine learning and EMA data to identify factors that predict children's energy intake

PROJECT SUMMARY
The collection of real time data through technology-based approaches, such as ecological momentary
assessment (EMA), presents a rich source of information for understanding concurrent predictors of children’s
eating behaviors. However, advanced statistical programming methods are needed to transition from real-time
assessment to real-time modification of eating behaviors. In order to complete the foundational step for this
transition, the proposed study aims to train and test a series of machine learning algorithms that identify and
describe the effects of concurrent contextual factors, including location, food preparation style, people present,
and presence of media devices, on children's subsequent energy intake. In Aims 1 and 2, algorithms will be
trained and tested on data across all children to evaluate their ability to identify factors that predict children’s
energy intake. By training and testing individual-specific algorithms in the Exploratory Aim, this research will
evaluate the ability to build personalized prediction models. To achieve the proposed aims, this research will
leverage EMA and dietary data from the Mothers And Their Children's Health (MATCH) study (R01 HL119255;
PI: Dunton), which used a longitudinal, observational, dyadic, case-crossover design, and enrolled 202
mothers and their 8 to 12 year-old children. By matching mothers' and children's EMA responses to the time-
stamped 24-hour dietary recall data, the proposed research will identify predictors of children's energy intake.
This proposal represents an innovative approach to studying children’s eating behaviors and brings together
cross-disciplinary training to pursue this line of work. With a strategic training plan that combines hands-on
experience in data analytics, coursework, and guided mentorship, the applicant will test the proposed aims and
develop skills and expertise critical for founding an independent research career in real-time interventions
using machine learning techniques. The applicant will work closely with her primary sponsor, Dr. Corby Martin
(an expert in mobile health interventions), her co-sponsors Dr. Genevieve Dunton (an expert in EMA
approaches), Dr. Sujoy Ghosh (an expert in computational biology and machine learning), and Dr. John
Apolzan (an expert in clinical nutrition trials). This sponsoring team, in combination with the resources available
through the Pennington Biomedical Research Center, represent the ideal conditions to accomplish the
applicant's research and training goals, facilitate professional development, and increase the applicant's
autonomy as an independent researcher.

Public health relevance
PROJECT NARRATIVE A better understanding of children’s eating behavior will lead to the development of innovative intervention strategies for preventing childhood obesity. The current F32 application is designed to employ machine learning techniques to identify factors that predict children’s eating behaviors based on ecological momentary assessment (EMA) data. The findings of the proposed research have the potential to inform personalized interventions that integrate EMA data and provide real-time feedback to promote healthy eating and prevent childhood obesity.